ECOD: Large scale classification of predicted and experimental protein structures

Project Summary
Classification of protein domains have historically served to contextualize the 3D structural data collectively generated by
experimental structure determination methods such as X-ray crystallography, nuclear magnetic resonance spectroscopy,
and electron microscopy. Our database, Evolutionary Classification of protein Domains (ECOD), has served the biological
community for seven years cataloguing evolutionary relationships between domains from experimental structures. The
recent advent of high-accuracy structure prediction methods, such as AlphaFold (AF) and RoseTTAFold (RF), and the
consequent release of 1 million predicted structures in AlphaFold Database (AFDB) heralds a paradigm shift in structural
biology and domain classification. The rate of structure deposition is expected to jump between a hundred to a thousand-
fold. We propose to take advantage of this revolution and transform ECOD into a comprehensive classification of the
entire protein university using sequence, structure, and functional evidence. By simultaneously classifying experimental
and predicted structures of proteins from model organisms and human pathogens, our classification will help the scientific
community to critically evaluate structure models and utilize the evolutionary information to discover and experimentally
characterize protein function.
Classifying AF models challenges the ECOD pipeline by a 50-fold increase in the workload and by the significant fraction of
non-globular and low-quality regions in the models. Thus, our first Aim is to upgrade ECOD’s infrastructure and develop
methods to identify single domains from AF models and to integrate sequence, structure, and functional site similarities
into our automatic classification. Compared to the current ECOD workflow that relies on human experts for structure-and-
function-based classification, these improvements will drastically decrease the need for manual curation and will allow us
to achieve our second Aim, i.e., classifying domains of over 1 million released AF models into ECOD via a combination of
computational pipelines and minimal manual efforts (0.25%  1% cases). Utilizing the deluge of AF models, the new
automatic pipeline, and expertise of human curators, we expect both to significantly improve ECOD and to evaluate the
quality of AF models by (1) covering all known protein families in Pfam, (2) confirming remote homology via evolutionary
intermediates, (3) comparing evolutionarily related experimental and predicted structures, and (4) resolving errors and
inconsistency through periodic quality checks. Finally, we will take the lead in making functional discoveries for
biomedically important proteins classified by ECOD in our third Aim, studying virulence factors (VFs) in bacterial pathogens
modelled by AFDB or studied by our experimental collaborators, the Orth lab. Fast evolving VFs were a challenge for
structure prediction or functional inference by sequence. We will identify candidate VFs in two dozen bacterial pathogens,
obtain their structure models, and infer their function using similarities to known proteins in structure and functional sites.
Promising hypotheses will be tested experimentally in the Orth lab through biochemical and genetic assays.

Public health relevance
Project Narrative We will compile the first comprehensive evolutionary classification of the protein universe by categorizing millions of proteins with accurately predicted 3D structures, enabled by the recent breakthrough in protein modelling facilitated by Artificial Intelligence. Our classification will accelerate discovery and characterization of proteins involved in pathogenicity and human diseases by association of novel and uncharacterized proteins with their well-studied relatives and guide experimental studies.